Long-term Effects of a Natural Disaster on Cognitive Aging, Dementia, Health and Well-being of Older Adults

Abstract
This project will provide rigorous scientific evidence on the effects, over the long-term, of
exposure to stressors on cognitive performance, physical and psychosocial health and well-
being of older adults in Indonesia using extremely rich population-representative longitudinal
data collected from about 12,000 older respondents (>40y) before and for 20 years after the
2004 Indian Ocean earthquake and tsunami, the Study of the Tsunami Aftermath and Recovery
(STAR). The tsunami was a large and unanticipated natural disaster that devastated some
coastal communities while other comparable, nearby communities were untouched because of
the wave direction, land and seabed topography. Exposure to the tsunami is, therefore,
plausibly exogenous in our study area, coastal Aceh and North Sumatra, so that estimated
effects of exposure to the stress of the tsunami can be given a causal interpretation. We will
investigate how these effects vary with the nature of individual-specific experiences of the
tsunami including being caught up in the water, losing family and loss of economic livelihoods.
The research will document the extent of resilience and recovery among older adults in the face
of the tsunami and its aftermath, as well as the role played in these processes by individual,
household, family and community resources, including post-tsunami reconstruction.
Special attention is paid to the measurement and interpretation of cognition and health. All older
respondents will complete assessments used to screen for Alzheimer's disease which will be
clinically validated. For a randomly selected sub-sample of older respondents, the screeners will
be complemented with innovative neuroscience-based measures of executive functioning and
emotional control assessed on tablets in the home. Validated cardio-metabolic biological risks
will be collected for the same subsample of older adults to provide uniquely rich, high quality
measures of key outcomes designed for this research. The links between cognition and health
will be described using contemporaneous measures and exploiting longitudinal data on health
that reach back 15 years.

Public health relevance
Narrative: This project sees to better understand how cognition, Alzheimer's Disease and other dementias, and cardiometabolic health are affected by and evolve after exposure to extreme stressors from a natural disaster. The project will analyze anthropometrics, blood-based biomarkers, and results of cognitive tests collected from a population differentially exposed to an extreme event. The project will provide critical information on the long-term implications of extreme events for health.